Administration and Advocacy

SUMMARY
Our Breast SPORE consists of three full research projects as well as developmental projects, career
development, and specialized core resources. An Administrative Core is needed to efficiently utilize
administrative personnel and to provide common services for these projects and cores. Dr. Matthew Ellis,
as Principal Investigator of the SPORE, will direct this Administrative Core. The Core will support
communication and integration among SPORE members, organize regular SPORE membership meetings
as well as conferences and seminars, and assist in coordinating clinical trials management within the SPORE
projects. The Core also provides a pool of services which are common to all components of the SPORE,
including: financial administration of grant funds and the Director’s discretionary funds, organization of
conferences and seminars, administrative processing of review and funding of Developmental Projects,
management and review of Developmental Projects, coordination of travel, report preparation, monitoring
Human Subjects training, conflict of interest reporting and management, and assurance of compliance with
all NIH and institutional grant regulations. The Core will also coordinate the services of our Internal Advisory
Board and Advocates Committee, and arrange for the visits of our External Advisory Board members to
review our progress and make recommendations. In summary, consolidation of common support and
administrative functions relieves individual projects of many minor but important tasks, and assures quality
control in record-keeping, services, and compliance issues. Core personnel are highly experienced, and the
Core provides well-organized and cost-effective support to all components of the SPORE

Public health relevance
NARRATIVE The Administrative Core is charged with facilitating communication and sustaining integration among the SPORE members and projects, as well as providing efficient support services for all of the SPORE components, in order to maximize synergy in achieving our translational research goals